Systems Science Approaches to Understand Neighborhood Opportunity and Racial/Ethnic Disparities in Maternal Morbidity

Rising maternal mortality rates, and the significant racial/ethnic disparities that characterize them, result in
black women dying from pregnancy-related causes at three to four times the rate of their white counterparts.
Considering that for every maternal death, over 100 women experience severe maternal morbidity —a life-
threatening diagnosis or condition occurring as a direct result of pregnancy and childbirth—the implications of
reducing maternal morbidity for black maternal health are profound. Morbidity during the postpartum period, as
represented by postpartum hospital readmissions, is also 30% more likely to impact black women. Effective
interventions developed from a comprehensive, multilevel evidence base are needed to successfully eliminate
these disparities. However, many of these multilevel factors remain understudied, and translation of evidence
into action remains challenging due to complex inter-relationships across factors that produce unanticipated
outcomes. The objectives of this study are to address this twofold gap by 1) investigating neighborhood
opportunity access as an understudied multilevel factor in relation to racial/ethnic disparities in maternal
morbidity and 2) using systems science methodologies, such as system dynamics, in a participatory framework
to develop a causal system map that contextualizes the role of neighborhood opportunity access within the
complex, inter-related system shaping racial/ethnic disparities in maternal morbidity. Using Philadelphia, PA as
a base case, I will partner with the Maternal, Child, and Family Health Division in the Philadelphia Department
of Public Health to leverage linked hospital discharge, birth record, and neighborhood indicator data to
accomplish the following aims: (1) To estimate associations between neighborhood opportunity access and
severe maternal morbidity, using a composite measure that includes indicators from the social, physical, and
built environment, and assess whether it explains racial/ethnic disparities; (2) To estimate associations
between neighborhood opportunity access and postpartum hospital readmissions, and assess whether it
explains racial/ethnic disparities; (3) To develop a qualitative system map detailing the causal feedback
structure driving associations between neighborhood opportunity access and racial/ethnic disparities
peripartum maternal morbidity, contextualized within an ecosystem of other multilevel factors, using
participatory system dynamics methodologies. The K01 will allow me to gain integral training in the use of
administrative data for population health, advanced spatial statistics to geospatially contextualize health
disparities, and participatory systems science methodologies to support the translation of evidence into action
to eliminate health disparities. This will help me achieve my long-term goal of successfully building a rigorous
research agenda that uses applied methodologies to understand the sociostructural determinants of
racial/ethnic disparities in maternal and infant health and informs the development of sustainable policies and
programs to eliminate them.

Public health relevance
PROJECT NARRATIVE Considering that there are 100 cases of maternal morbidity for every maternal death in the US, addressing the rising rates and racial/ethnic disparities in maternal morbidity across the peripartum period has critical implications for improving the short- and long-term health of women of color. Achieving the dual goals of this study, to build the evidence base on neighborhood context as a determinant of racial/ethnic disparities in peripartum maternal morbidity and contextualize that evidence within the complex system of interrelationships with other multilevel determinants of these outcomes, will support the development of innovative interventions to eliminate racial/ethnic disparities in peripartum morbidity. This has significant implications for both improving the long-term health of women of color and reducing rates of maternal mortality in the US.